Gene-by-sex interactions in heart failure with preserved ejection fraction (HFpEF)

Project 2: Gene-by-sex interactions in heart failure with preserved ejection fraction (HFpEF)
PROJECT SUMMARY
Our laboratory has been interested in the basis of sex differences in cardiometabolic traits for the past two
decades. We use a “system genetics” approach that integrates clinical and molecular traits in the context of
genetic variation. For studies in mice we use a resource called the Hybrid Mouse Diversity Panel (HMDP) that
has a number of advantages for studies of complex traits. Our proposal is fucused on a poorly understood, but
common form of heart failure, called heart failure with preserved ejection fraction (HFpEF). It is characterized
by diastolic dysfunction and preserved ejection fraction, distinct from heart failure with reduced ejection fraction
(HFrEF). HFpEF is a highly complex disorder with multiple comorbidities, including obesity, diabetes,
hypertension, and inflammation. It is highly heterogenous and has a significant environmental component,
making human studies difficult. Consistent epidemiological data demonstrate that women are about twice as
likely to develop HFpEF as compared to men. They also tend to present with more symptom burden, including
signiﬁcantly increased diastolic dysfunction and enhanced left ventricle stiffness. However, the nature of sex
differences remains unclear. Because of the complexity of the syndrome, we have used a mouse model of
HFpEF that involves feeding mice a high fat diet and a nitric oxide synthase inhibitor. Our strategy is to perform
systems genetics analyses using this model in the HMDP and from this develop hypotheses that can be tested
in human cohorts. Our results thus far in mice have revealed that females tend to be more susceptible to diastolic
dysfunction and other HFpEF traits than males, consistent with the human epidemiological data. Aim 1 is
directed at understanding sex differences in HFpEF traits, particularly in the heart, at the molecular level. A long-
term goal is to model sex-specific biologic networks that can be generalized to humans. Aim 2 is directed at
understanding the cause of the sex differences. We have previously obtained evidence that sex hormones
explain, in part, the sex differences in HFpEF susceptibility and we now propose to examine sex chromosomes
using the Four Core Genotypes (FCG). During the course of our studies, we discovered that, in heart, males
have higher levels of mitochondrial function than do females, and we have proposed that this may explain the
sex difference. In Aim 3, we will now test this hypothesis by examining the roles of estrogen receptor alpha and
sex chromosomes in mitochondrial functions. We will also characterize in detail the mitochondrial enzyme,
ACSL6, that we have identified as causal for HFpEF.

Public health relevance
Project 2: Gene-by-sex interactions in heart failure with preserved ejection fraction (HFpEF) PROJECT NARRATIVE Heart failure with preserved ejection fraction accounts for 50% of all heart failure. It exhibits a strong sex bias, with about two-thirds of patients being women. We will dissect the basis of this sex difference using systems genetics approaches in mice as well as validation of hypotheses in human cohorts.